The 12th International Workshop on HIV Pediatrics

ABSTRACT The International Workshop on HIV Pediatrics is organized on an annual basis prior to the biennially organized IAS or AIDS Conference. This Workshop is the only meeting entirely devoted to research in prevention and treatment of HIV infection in infants, children and adolescents, making it the premier forum for the world’s leading researchers. By bringing together experts from different disciplines with presentations in a variety of formats, the meeting offers a collaborative setting where the latest developments are presented, discussed, interrogated and evaluated. The 12th International Workshop on HIV Pediatrics will be organized in San Francisco and Oakland, California, July 3-4, 2020. The program will include topics from among the following: 1) HIV infection in pregnant and breastfeeding women; 2) Prevention of mother-to-child HIV transmission (PMTCT), including HIV-exposed uninfected children; 3) Pediatric HIV case finding (including early infant diagnosis); 4) Antiretroviral treatment of pediatric HIV infection; 5) Complications of HIV and its treatment in children and youth; 6) Co-infections in children and youth living with HIV; 7) HIV infection and adolescents (perinatally and behaviorally infected); 8) Prevention of HIV and STDs in adolescents and young adults; 9) Implementation science research on optimizing care of children and youth and PMTCT; and 10) Pediatric remission/cure research. The meeting format is highly innovative. Moving from a more traditional format of plenaries and oral abstract sessions, the organizers have introduced several new approaches including structured debates, oral poster presentations, poster walks, clinical-case presentation and discussions, curated panel discussions, and video presentations. Plenaries include short presentations highlighting different facets of common issues followed by interactive discussions. Attendance has increased substantially in the last several years with almost 250 delegates in 2019 and annual evaluations are highly favorable underscoring the importance of this Workshop. The aims of the Workshop are to provide a platform for presentation and discussion of the latest developments in the field; to gather leading researchers involved in pediatric and perinatal HIV in a stimulating, interactive forum and; to promote the next generation of research by supporting junior and international investigators. The objective of this proposal is to provide support for this unique workshop including participation of key plenary speakers as well as members from the community of adolescents living with HIV infection, and to increase the number of scholarships for junior investigators and investigators from low-income countries.

Public health relevance
PROJECT NARRATIVE The International Workshop on HIV Pediatrics is the only meeting entirely devoted to research in prevention and treatment of HIV in infants, children and adolescents, making it the premier forum for the world’s leading researchers. By bringing together experts from different disciplines with presentations in a variety of innovative formats, the meeting offers a collaborative setting where the latest developments are presented and junior investigators are supported and encouraged to continue their scientific work in this field.